Role of Sympathetic Innervation in Islet Plasticity during Pregnancy.

Project Summary
Pancreatic islets of Langerhans are functional micro-organs that are essential for glucose homeostasis.
Loss or dysfunction of insulin-producing beta-cells in islets results in dysregulation of blood glucose levels and
leads to diabetes. An important goal in diabetes prevention and treatment is a better understanding of the
pathways governing expansion of beta-cell mass and function. Pancreatic islets do not exist in isolation, and an
area of emerging importance is the role of innervation in islet development and functions in health and disease.
Pancreatic islets are densely innervated by sympathetic nerves, as well as by parasympathetic nerves, although
to a lesser extent. Neuronal input is necessary to control hormone release in adult islets and maintain glucose
homeostasis. Previously, our laboratory showed that sympathetic innervation of islets during development is
essential for establishing islet architecture and for functional maturation in mice. Recent findings indicate that
islet innervation undergoes substantial structural changes in animal models of diabetes and in human tissues.
Together, these studies highlight a critical need to investigate the contribution of innervation to islet morphology
and hormone secretion in physiological and pathological conditions.
Pregnancy is a unique physiological condition when islets show striking morphological and functional
plasticity in adult life. In response to increased metabolic demand, adult beta-cells dynamically respond by
enhancing proliferation and their secretory function. However, the molecular mechanisms underlying the
structural and functional plasticity of islets during pregnancy remain largely unclear. Based on my preliminary
results, the overall goal of this project is to test the hypothesis that innervation contributes to islet plasticity during
pregnancy. I will test this hypothesis by defining anatomical and functional interactions between autonomic
nerves and the endocrine pancreas using whole-mount immunostaining, 3D imaging, and nerve ablation studies
in pregnant and control mice. Whole-organ imaging will preserve the spatial relationships between endocrine
islets and neighboring nerves. By performing genetic ablation of islet nerves, I will address the essential
contribution of nerves to adaptive changes in islet structure and function in pregnant mice.
Through this fellowship application, I will define a new regulatory pathway, specifically, the role of
peripheral nerves, in islet and beta-cell adaptation during a condition of high metabolic demand. I will also
develop the experimental, communication, and leadership skills necessary to accomplish my goal of becoming
an independent investigator. My training will be facilitated by the rigorous research plan, the expertise and
guidance of my mentor and thesis committee, and the outstanding training resources and facilities available
through Johns Hopkins University.

Public health relevance
Project narrative Dysfunction or loss of endocrine beta-cells leads to diabetes. Pancreatic islets receive neuronal input from sympathetic and parasympathetic nerves and these interactions are essential for hormone secretion. During pregnancy, beta-cells respond to high metabolic demand by increasing their mass and secretory function. The goal of this project is to address the role of sympathetic nerves in regulating the structural and functional plasticity of beta-cells during pregnancy using whole organ clearing, 3D imaging, and nerve ablation studies in mice.